Biocompatibility testing of the COSMIIC System

Abstract Summary
Biocompatibility testing of the COSMIIC System
The aim of this supplement is to conduct biocompatibility testing of the COSMIIC System
components, under currently accepted standards (ISO 10993-1), and to make the testing
procedures and results available to the public under our open source licenses. The Specific Aims
of this supplement are:
Specific Aim #1 Complete a Q-Sub with the FDA to gain insights into biocompatibility
requirements for a device covered in an Early Feasibility Study (EFS) Investigational Device
Exemption (IDE).
Specific Aim #2 Generate a comprehensive Biological Evaluation Report (BER).
Specific Aim #3 Develop a toxicology risk assessment based on chemical characterization and
test results.
Specific Aim #4 Publish all test procedures (to the extent allowable) and all test results freely
available under the COSMIIC open source licenses.

Public health relevance
Project Narrative Biocompatibility testing of the COSMIIC System The aim of this supplement is to conduct biocompatibility testing of the COSMIIC System components and to make the testing procedures and results available to the public under our open source licenses.